Multiresolution FLIM and Reflectance Confocal Microscopy to Detect Dysplasia

DESCRIPTION (provided by applicant): Approximately 35,000 patients in the United States are diagnosed annually with cancer of the oral cavity, and 7,500 Americans die of this disease each year. The long-term goal of this research is to design, construct, and test a novel multiresolution fiber optic endoscope combining wide-field fluorescence lifetime imaging (FLIM) and reflectance confocal microscopy (RCM) to achieve unprecedented sensitivity and specificity of epithelial precancers in vivo. Subcellular resolution and the associated computational framework will enable interpretation of the resulting images to yield diagnostic information based on physiological, biochemical, and morphologic changes. The specific goal of this proposal is to apply the resulting multiresolution FLIM-RCM system to detect oral precancer. The specific aims of this proposal are to: 1) construct a bench-top multiresolution FLIM-RCM system to demonstrate the capability of FLIM-RCM to characterize normal, dysplastic, and cancerous tissue; 2) design and construct a fiber-based handheld FLIM-RCM probe for in vivo imaging of oral precancer and cancer; 3) optimize the sensitivity and specificity of FLIM-RCM for early detection of oral cancer; and 4) demonstrate the capability of FLIM-RCM to detect epithelial precancer in vivo. The successful completion of this work will enable the development of the first fiber-based multiresolution FLIM-RCM system for tissue characterization and will demonstrate its potential for non-invasive optical detection of oral premalignant and malignant lesions. This novel technology has significant potential to become a clinical diagnostic and screening tool, a navigation system for guiding standard biopsy and surgical intervention, and a tool for quantitative evaluation of responses to current and novel chemopreventive and therapeutic interventions. Although this proposal is focused on the detection of oral precancer, the imaging system and algorithms developed will be generally applicable to many of the cancers of the epithelium (e.g., cervix, colon, rectum, and bladder).

Public health relevance
PUBLIC HEALTH RELEVANCE: Approximately 35,000 patients in the United States are diagnosed annually with cancer of the oral cavity, and 7,500 Americans die of this disease each year. The relative five-year survival rate for patients diagnosed with oral cancer drops from 82% when detected early at the local stage to 27% when detected after distant metastasis. Early detection is thus critical. The goal of the proposed research is to develop a novel optical imaging tool to improve early detection of precancerous lesions in the oral cavity. Narrative Approximately 35,000 patients in the United States are diagnosed annually with cancer of the oral cavity, and 7,500 Americans die of this disease each year. The relative five-year survival rate for patients diagnosed with oral cancer drops from 82% when detected early at the local stage to 27% when detected after distant metastasis. Early detection is thus critical. The goal of the proposed research is to develop a novel optical imaging tool to improve early detection of precancerous lesions in the oral cavity. __SpecificAimsTextDelimiter__ B. SPECIFIC AIMS Each year, over 6 million people die from cancer and over 10 million new cancer cases are detected worldwide [8]. Approximately 85% of cancers originate in epithelial organs, such as the oral cavity, colon, bladder, and cervix. For cancer in these organs, the relative five-year survival rate drops from almost 90% when detected early at the local stage to 12% when detected after distant metastasis [9]. Early detection is thus critical. Diagnosis of dysplasia requires identification of physiological, biochemical, and morphological changes that accompany carcinogenesis. Various optical spectroscopic and imaging techniques are being explored for in vivo detection of epithelial cancers, due to their potential for detecting and quantifying each of these changes in epithelial tissues. Additionally, epithelial tissues, such as the oral mucosa, are particularly well suited to optical imaging, because of their ease of access for the requisite optical probes. Fluorescence lifetime imaging (FLIM) has demonstrated capability to detect metabolic and biochemical changes associated with the development of precancer with high sensitivity, but lateral resolution and lack of depth sensitivity are limitations. Reflectance confocal microscopy (RCM) has been shown to detect subcellular morphologic changes and tissue architectural changes accompanying dysplasia, however it is effectively a point measurement. We propose to build a multiresolution optical system capable of performing co-registered macroscopic wide-field fluorescence lifetime imaging and high resolution reflectance confocal microscopy in vivo for early detection of oral dysplasia. Combining wide-field FLIM and RCM will provide fluorophore specific, large area inspection followed by depth sensitive, high resolution microscopy of suspicious lesions. Because the proposed instrument will allow simultaneous characterization of tissue morphology, physiology, and biochemical composition at macroscopic and microscopic levels, we hypothesize that it will increase the sensitivity and specificity for characterizing early cancer development. The specific aims of this proposal are: Aim 1: To construct a bench-top multiresolution FLIM-RCM imaging system based on our previously demonstrated individual imaging systems. The design specifications for FLIM-RCM will be optimized using the hamster cheek pouch model of oral carcinogenesis so that biochemical and morphological features can be imaged in normal, premalignant, and malignant tissue. Aim 2: To design and construct the first fiber-based multiresolution FLIM-RCM probe for in vivo imaging of epithelial precancer and cancer. Based on design parameters determined from the benchtop system and preliminary animal imaging in Aim 1, a miniaturized imaging probe for simultaneous wide-field FLIM and high resolution RCM imaging will be designed for use in the human oral cavity. Aim 3: To optimize the sensitivity and specificity of the proposed multiresolution FLIM-RCM imaging technology for early detection of epithelial precancer. A baseline database of multiresolution FLIM-RCM images from human oral tissue and the underlying tissue histopathology will be acquired using the fiber-based system resulting from Aim 2. Normal tissue from volunteers will be imaged in vivo, and precancerous and cancerous tissue from biopsies and surgically excised tissue will be imaged ex vivo. Computational methods for classifying the oral tissue will be developed, and their accuracy to detect dysplasia will be quantified. Aim 4: To demonstrate the capability of multiresolution FLIM-RCM to detect epithelial precancer in vivo. A validation database of multiresolution FLIM-RCM images from oral tissue and the underlying tissue histopathology will be acquired using the fiber-based system. Normal, precancerous, and cancerous tissue from human patients will be imaged in vivo. The accuracy of the proposed imaging instrument and computational methods to prospectively detect oral dysplasia will be quantified. The team assembled brings together expertise in fiber optic in vivo reflectance confocal microscopy (Dr. Maitland), fluorescence lifetime spectroscopy and imaging (Dr. Jo), a hamster cheek pouch carcinogenesis model (Dr. Gimenez-Conti), and oral oncology and pathology (Drs. Cheng, Wright, Read, and Acosta). The successful completion of this work will enable the development of the first fiber-based multiresolution FLIM- RCM system for tissue characterization and will demonstrate its potential for non-invasive optical detection of oral premalignant and malignant lesions. This novel technology has significant potential to become a clinical diagnostic and screening tool, a navigation system for guiding standard biopsy and surgical intervention, and a tool for quantitative evaluation of responses to current and novel chemopreventive and therapeutic interventions. Although this proposal is focused on the detection of oral precancer, the imaging system and algorithms developed will be generally applicable to many of the cancers of the epithelium (e.g., cervix, colon, rectum, and bladder). Similarly, although this application focuses on endogenous autofluorescence and reflectance, the technology could easily be adapted to image tissue with the use of specific contrast agents.